Polygenic Risk Stratification for Cardiovascular Disease in Young Male Veterans presenting with Erectile Dysfunction

SUMMARY
Erectile dysfunction (ED) affects up to 62% of Veterans and represents a common, yet
underappreciated component of multi-morbidity. In addition to the negative impact of ED on
quality of life, ED is also an independent risk factor for cardiovascular disease and can
represent a precipitating condition for a major adverse cardiac event (MACE). The reliable
identification of men with ED who should initiate intensive CVD risk reduction therapies
represents a key knowledge gap. There is a critical need for ED-specific precision medicine
approaches for the prevention of MACE. This proposal uses innovative approaches on big data
from the Million Veterans Program (MVP) to better understand causes of ED and improving
CVD risk prediction. The overarching hypothesis is that the risk of CVD in men with ED is
variable and dependent on the differential, causal contributions from associated cardiometabolic
traits and psychiatric conditions. To accomplish the three research aims, we will first start by
assessing multimorbidity burden in Veterans with ED in Aim 1. Using clustering analysis of
individuals with ED, we will identify multiple subtypes of ED based on multimorbidity burden.
These ED disease clusters will be assessed for their differential association with MACE. In Aim
2, we will leverage genome wide association studies (GWAS) to explore causal inference for
cardiometabolic and psychiatric traits with ED using population-specific and multi-population
Mendelian Randomization approaches. Additionally, we will perform a GWAS for ED within the
larger, more ethnically diverse MVP and meta-GWAS with other large genetic datasets to
identify additional risk variants for ED and improve the statistical power of our analyses in Aim 2
and Aim 3. Lastly, in Aim 3, we will assess the differential, causal effect of drugs used for
cardiometabolic and psychiatric conditions on ED by using drug-MR analyses, leveraging DNA
variants for genes encoding these drug targets. Successful completion of this VA Career
Development Award-2 (CDA-2) will enable the candidate to become a VA surgeon-scientist and
establish an independent VA-based research program to improve Veteran health and well-
being.

Public health relevance
NARRATIVE Erectile Dysfunction can be a warning sign of a future heart attack or stroke. The smaller diameter arteries of the penis are more likely to become blocked from atherosclerotic plaque prior to the larger arteries in the heart or brain. Although cardiovascular disease prevention has broadly focused on the modifying shared risk factors between erectile dysfunction and cardiovascular disease like high blood pressure, it is difficult to identify men with erectile dysfunction who are at the highest risk of cardiovascular complications, especially among young and ethnically, diverse men. We will analyze electronic health records and genetic data in a very large number of Veterans and non-Veterans to better understand the relationship between erectile dysfunction and cardiovascular disease. This new knowledge will help us improve Veteran health outcomes and quality of life by developing individualized approaches to reduce the risk of cardiovascular disease in those presenting with erectile dysfunction.